Motion and Distortion Robust Diffusion Weighted Imaging Sequences for Pediatric Patients

Project Summary
In pediatric epilepsy patients with drug-resistant seizures, surgical resection is the most effective treatment
option. The goal of resective surgery is to maximize removal of epileptic foci to attain seizure-freedom while
minimizing damage to surrounding brain regions to avoid permanent post-surgical functional loss. Diffusion
MRI enables rapid and non-invasive pre-surgical mapping of language, motor skills and other critical functional
brain regions with high spatial resolution. However, excessive head motion presents a major limitation for
acquiring high-quality diffusion MRI in pediatric patients with focal brain lesions, who usually have difficulty
remaining still for long scan durations. Unfortunately, current retrospective and prospective approaches cannot
adequately compensate for the complex effects of motion in diffusion MRI. As echo planar imaging (EPI) is
highly susceptible to local magnetic field variations, motion-induced geometric distortions can lead to
potentially significant mislocalization of important brain regions, even with accurate head motion tracking. The
overarching goal of the research proposed under this application to the NIH is to dramatically improve the
quality of diffusion MRI for pre-surgical mapping in pediatric epilepsy patients. We are proposing a solution
based on a dual-echo EPI sequence, which was shown to produce high quality slice level distortion maps that
can be used to correct motion related artifacts. We will generate a pipeline that produces motion and distortion
free images on the scanner with the utilization of an online reacquisition and distortion correction strategy. We
hypothesize that this improved diffusion MRI acquisition strategy will produce technically useful tractography in
pediatric epilepsy patients evaluated for a resection surgery at a higher rate than previously thought possible.
To achieve these ambitious goals, we will undertake the following specific aims: Specific Aim 1: Develop,
optimize and evaluate a dual echo sequence for slice level geometric distortions correction; Specific
Aim 2: Develop and evaluate a novel prospective motion correction technology that estimates and
corrects geometric distortions at each position; Specific Aim 3: Develop and evaluate tools for on-
scanner motion and distortion correction, reacquisition and diffusion parameter estimation; Specific
Aim 4: Apply and evaluate motion and distortion compensation technologies in DW-MRI of pediatric
candidates for epilepsy surgery: If successful, our project will facilitate widespread clinical adaptation of
diffusion MRI for pre-surgical mapping in epilepsy, and enable high resolution diffusion MRI for research
studies in incompliant patient populations.

Public health relevance
Project Narrative Epilepsy surgery can result in seizure freedom or a marked reduction in seizures in approximately two-thirds of children with intractable seizures who have been carefully selected, with minimal adverse functional loss. Diffusion weighted magnetic resonance imaging (DW-MRI) is an important non-invasive tool that allows the neurosurgeon to precisely map regions of the brain supporting critical functions that should be preserved; however, excessive head motion can lead to mis-identification of these regions, with direct implications for treatment. The proposed project, “Motion and distortion robust diffusion weighted imaging sequences for pediatric patients” promises to deliver a highly innovative imaging method capable of producing high-quality connectivity maps in the presence of uncontrolled head motion by tracking the position of the head and updating the acquisition in real-time.